Caregiving effects on the early development of infant brain-behavior relationships

ABSTRACT
The rapid development of the human brain in the first years of life determines critical brain-behavior
relationships that are likely to set the stage for future clinical and functional outcomes. In parallel, infant
behavioral studies show that high levels of negative emotionality (NE), low positive emotionality (PE), and
emotional dysregulation are early risk factors for subsequent child behavioral and emotional problems.
Emerging research also indicates a critical role of caregiving in shaping early brain-behavior relationships. Yet,
little is known about the interface between functioning and structure in neural circuitries underlying emotional
reactivity and early emotional regulation, the behavioral manifestations of these circuitries, and the ways in
which caregiving quality might influence this neurobehavioral development. Our preliminary data
(R21MH106570) show significant links between compromised white matter and intrinsic (resting state)
functional connectivity in prefrontal cortical-subcortical emotional reactivity/ regulation circuitry in 3-month
infants and independent observations of: 1) high NE relative to PE assessed concurrently; and 2) emotional
dysregulation assessed 6 months later. We have also shown that insensitive maternal behavior at 3 months is
associated with disrupted relationships between infant brain structure and intrinsic functional connectivity, and
NE and PE. We now propose a larger-scale, longitudinal study of 120 infants, which will examine the predictive
utility of infant brain structure and intrinsic functional connectivity at 3 and 9 months, and changes between 3
and 9 months, on trajectories of NE, PE and emotional regulation from 3 to 18 months, and the impact of
caregiving on these developing brain-behavior relationships. Infants will be sampled across the spectrum of
risk for emotionality and emotional dysregulation, as a function of caregiver report of emotional instability in the
postpartum period. Infants will undergo MRI scans during sleep at 3 and 9 months. PE, NE and emotional
regulation will be measured at 3, 9 and 18 months, via primary caregiver reports and independent
observations. Caregiving behavior will also be assessed in separate sessions with the infant at 3, 9 and 18
months. We aim to examine: 1) prospective relationships among neural circuitry structure and intrinsic
functional connectivity at 3 and 9 months, and change from 3 to 9 months, and: 3-18 month changes in
emotional reactivity and regulation; and 2) the influence of caregiving on these brain-behavior relationships
across the first 18 months of life. Exploratory analyses will also explore the effect of the sex of the infant upon
infant brain-behavior relationships. Elucidating these brain-behavior relationships early in life will help identify
objective neural markers among at-risk children before clinical problems emerge, and provide targets for new
interventions to improve the health and well-being of children at risk for future psychopathology.

Public health relevance
PROJECT NARRATIVE Little is known about the developing relationships between neurobiology and emotional regulation in early human infancy. Building on findings from our preliminary work, we propose to examine relationships among 3- month infant brain structure and function, developmental changes in these measures between 3 and 9 months, and emotional reactivity and regulation capacity across the first 18 months of life, within a caregiving context. The findings from this study will help provide neurobiological markers to identify infants who are at risk for future behavioral and emotional problems before these problems are manifested, and will guide early interventions that can improve the health and well-being of at-risk infants and young children.